Allosteric Pharmacologic Chaperones for alpha-1 Antitrypsin Mutants

Project Summary/Abstract
The major deficiency E342K mutant or “Z-variant” of the abundant serum antiprotease Alpha-1 antitrypsin
(AAT) is responsible for the vast majority of morbidity and mortality associated with Alpha-1 antitrypsin
deficiency (AATD), a leading cause of hereditary lung and liver disease affecting millions of patients globally.
This missasembly-prone variant is known to be highly polymerogenic, owing to a widened -sheet A domain
which predisposes the AAT-Z monomer to form cytotoxic loop-sheet oligomers. These toxic oligomers
accumulate in producing hepatocytes leading to chronic liver disease, and build up extracellularly leading to
both gain-of-toxic function in the lung with a concomitant loss of serum AAT-Z antiprotease activity which leads
to proteolytic destruction of lung parenchyma by neutrophil proteases like elastase. Crystal structures of
monomeric AAT-Z have been studied and previous mutational analyses have demonstrated the capacity for
space-filling mutations within surface-accessible hydrophobic pockets on this protein to prevent polymerization
without abrogating antiprotease activity. It has thus been hypothesized that small molecules could be
discovered which act as pharmacological chaperones, preventing AAT-Z polymer formation while permitting
native antiprotease activity of the stabilized monomer, serving to ameliorate the multiorgan injury (including
lung pathology) associated with AATD. While stabilizing ligands for AAT-Z have previously been reported,
these ligands universally fail to permit the native antiprotease activity of AAT-Z. In this training proposal, I
propose to use Fully-Functionalized Fragment” (FFF) substructures along with photo-crosslinking, affinity
chromatography and tandem mass-spectrometry in Aim 1 to identify the small molecule sites on the AAT-Z
monomer accessible to binding by drug-like substructures. In Aim 2 I will develop a novel screening assay that
I conceived of for identifying AAT-Z stabilizing ligands or pharmacologic chaperones that prevent RCL insertion
while permitting antiprotease activity of ligand-bound AAT-Z. In Aim 3 I will employ a cell-based phenotypic
assay already developed and validated by our collaborators in the Balch Lab to simultaneously evaluate the
capacity for screening hits to restore functional monomeric AAT-Z secretion efficiency, while reducing
intracellular oligomers in cultured hepatocyte and pulmonary cell models of AATD. This project will afford a
multidisciplinary training experience with guidance from experts in the fields of protein misfolding biology,
chemical proteomics, high-throughput assay development, as well as AATD patient treatment. Through the
research proposed herein, I will develop a robust expertise in state-of-the-art methods for proteomic analysis,
screening assay optimization, and applications of mammalian cell models of disease. These valuable
discovery-oriented research competencies, together with my previous training background in pre-clinical
medicine and medicinal chemistry will serve to enable a highly productive future career as a leading physician-
scientist researcher in the challenging field of first-in-class drug discovery.

Public health relevance
Project Narrative The misassembly-prone “Z-variant” of the serum antiprotease Alpha-1 antitrypsin (AAT) is associated with >95% of clinical pathology in over 3 million patients afflicted with Alpha-1 antitrypsin deficiency (AATD) worldwide. Small molecule pharmacologic stabilization of AAT to prevent toxic misassembly or polymer formation has proven feasible as a strategy for treating AATD liver pathology in cellular models, but a chaperoning ligand capable of allosterically preventing polymerization while also permitting native antiprotease function, the latter expected to address the loss-of-function component of lung disease, has proven elusive. This application focuses on the use of chemo-proteomic mapping to empirically identify all AAT-Z binding sites, to identify the binding sites of hits emerging from the concurrently performed target-based and phenotypic screening efforts focused on the discovery and mechanistic characterization of first-in-class allosteric pharmacologic chaperones which retain AAT's ability to react with and inhibit elastase.